ORAL THEOPHYLLINE AND AEROSOL BECLOMETHASONE DIPROPIONATE THERAPY OF ASTHMA

To compare the advantages and disadvantages of sustained release theophylline and inhaled steroids as principal long-term treatment of patients with asthma.